IDENTIFICATION AND CHARACTERIZATION OF RECEPTORS FOR GI PEPTIDES

These studies involve the identification of receptors for gastrointestinal peptides by developing selective radioligands for specific receptors, specific potent antagonists, and the characterization of receptors using these ligands, antagonists, cross-linking studies, solubilization and eventually structural determination.